An integrated approach to melanoma metastasis and therapy resistance: effects of age-related changes in the ECM and the biomechanics of the skin

Project Summary
The microenvironment plays a unique role in the development of melanoma, which arises in the skin. The skin
displays externally visible signs of aging, such as decreased elasticity and a loss of collagen integrity. Much
work has focused recently on how changes in collagen can affect tumor metastasis, both biomechanically and
biochemically. Data from several groups indicate that the cross-­talk between stromal fibroblasts and
transformed melanocytes is important for invasion, melanoma growth, and even therapy resistance. Our
proteomics analyses indicate that factors used to crosslink collagen, such as HAPLN1 are secreted by young,
but not aged dermal fibroblasts, and Wnt5A is secreted by aged, but not young fibroblasts. The interplay
between these molecules may contribute to age-­related changes in collagen integrity. We hypothesize that
changes regulated by age-­related alterations in the extracellular matrix (ECM) initiate or promote a pro-­
metastatic program, and impact therapy resistance.

We will query the contribution of aged skin biochemical and architectural contributions in governing
melanoma’s metastatic progression as well as resistance to targeted therapy. We propose an alternate theory
of matrix stiffness that hypothesizes that increasing stiffness will have a non-­linear effect on metastatic
progression, and therapy resistance. We will use pathophysiologically relevant in vitro 3D stromal systems (3D
skin reconstructions), animal models of melanoma, a novel simultaneous multi-­channel immunofluorescent
analysis (SMIA) of formalin-­fixed and paraffin embedded (FFPE) human tissue cohorts in combination with a
customized new software written for the bulk analysis and acquisition of SMIA-­generated images, single
molecule RNA imaging coupled with high-­throughput single cell imaging and sequencing, all of which will feed
back into an increasingly intricate mathematical modeling for improved understanding and better patient
personalized (i.e., metastatic and efficacy of drug treatment) prediction capabilities. We expect our data will
reveal a synergistic picture of the mechanochemical interactions between the aged microenvironment and
singular tumor cells that the individual approaches could not have deciphered.

This team project involves experts in the biology of melanoma metastasis, Wnt signaling and aging
(Weeraratna), single cell RNA systems biology (Raj), tumor-­stromal interactions and digital imaging
quantitative analyses (Cukierman) and computational and mathematical predictive modeling (Shenoy).

Public health relevance
Project Narrative The rate of melanoma development, progression and therapy resistance is greatly increased in the aging population, however the reasons for this are still unclear. We analyzed normal skin cells (fibroblasts) for changes during aging, and found that the most significant changes that occurred were those involved in the architecture of collagen and the integrity of the extracellular matrix. We will use sophisticated mathematical models, high- level imaging studies, and the analysis of the change in the tensile forces of collagen on single cells to uncover mechanisms by which the breakdown of collagen and the extracellular matrix in the aging skin promotes melanoma metastasis and therapy resistance.